NNLM Region 5: Reaching More People in More Ways

PROJECT SUMMARY/ABSTRACT – Admin Core, NNLM Region 5 RML/University of Washington (UW)
Reporting to Tania Bardyn, PI/Director, key personnel in the Region 5 Regional Medical Library (RML) will
include Associate Director Catherine (Cathy) Burroughs, who will supervise and manage personnel to carryout
programs and services of the cooperative agreement for the Network of National Library of Medicine (NNLM)
Region 5 based at the University of Washington Health Sciences Library in Seattle, Washington. Ms. Bardyn is
Associate Dean for University Libraries; Director of the Health Sciences Library; Adjunct Assistant Professor in
the UW School of Medicine Biomedical Informatics and Medical Education department; and is PI of the 2016-
21 NNLM Region 5 RML Cooperative Agreement. Ms. Bardyn has 24 years of professional experience working
in academic health sciences libraries in public and private institutions as an educator and administrator. She
has expertise in budgeting, accreditation, grants administration, negotiation, leadership development programs
and biomedical decision support systems. As PI/Director, Ms. Bardyn will chair and Catherine (Cathy)
Burroughs will serve as ex-officio the Region 5 Executive Committee (EC) for Region 5. EC members from 9
partner institutions in 6 states will be the first level of oversight in the governance structure that assures
initiatives are aligned and widely understood by Region 5 members. The 10 partners from 9
universities/organizations include: University of Alaska, Fairbanks (AK); University of Washington (WA);
Washington State University (WA); Orbis Cascade Alliance (OR); Portland State University (OR); Cal State,
Los Angeles (CA); UCSF (CA); University of Hawaii (HI); University of Nevada, Reno (NV). If awarded, UCLA
would be invited to serve on the Executive Committee. The governance model includes a total of two levels of
oversight from inter-institutional and regional leadership. This outward facing and participatory structure is
designed to increase visibility and accountability of Region 5 programs and services, promote membership
development, and encourage member input and participation. The third level of oversight will be the National
Network Steering Committee, to which the PI/Director, Tania Bardyn, will be the Region 5 RML representative.
Administration provides stewardship of all NNLM Region 5 funds, maintains appropriate systems for managing
all financial resources and data, and manages all reporting for the parent grant as well as leading the business
planning for services and programs, including administration of inter-institutional fiscal policies to maximize the
impact of grant funds. The Region 5 RML will liaise and collaborate with other RMLs, Offices and Centers and
the Office of Engagement and Training (OET) to identify and solve problems, leverage regional expertise and
avoid duplication of effort. Region 5 will participate in development, review and support of a regional
preparedness & response plan, including serving as back-up for NLM customer service inquiries during
regional or national emergencies.